Breast Cancer Program

The goal of the Program is to further our understanding of the biology of breast cancer and to provide scientific support and rationale for preclinical and clinical efforts to improve the detection, prevention, treatment and outcome of breast cancer. Membership, activities and research accomplishments for each of these groups are described below. Breast Cancer Program members work collaboratively both together and with members of other ACC program within these areas, as demonstrated by the transdisciplinary nature of the majority of projects described below.